Innate Immune Response to Aspergillus fumigatus Cell Wall Carbohydrates

Project Summary/Abstract
Invasive fungal infections are associated with exceptionally high mortality rates often exceeding 80%, and are
increasing in incidence due to a rapidly growing population of immunocompromised patients. Aspergillus
fumigatus is one of the leading causes of invasive fungal infections and causes a spectrum of diseases ranging
from skin and soft tissue to disseminated infections. Amongst patients that received hematopoietic or solid-
organ transplants, approximately 10% will develop invasive aspergillosis. The persistently high mortality rates
despite antifungal therapy highlights the deficiencies in our current antifungal armamentarium and the critical
role that the immune system plays in the clearance of infections. Effective fungal immunity is initiated by innate
immune recognition of the complex, carbohydrate fungal cell wall followed by cytokine production, ROS
generation, phagocytosis and killing of pathogens. The profile of fungal carbohydrate antigens displayed on the
fungal cell wall dictates the pattern recognition receptors engaged and influences whether a protective or non-
protective response is generated. In this application, the candidate proposes a K08 Mentored Clinical Scientist
Research Career Development Award grant that will characterize molecular mechanisms of macrophages and
neutrophil response to the A. fumigatus carbohydrates, galactomannan (GALM) and galactosaminogalactan
(GAG). To define the subcellular pathways involved in the response to these carbohydrates, novel fungal like
particles (FLP) composed of single purified carbohydrates stably coating polystyrene beads will be utilized.
Preliminary data suggests that Dectin-2 is a receptor for GALM. Specific Aim 1 will define the role of Dectin-2
in macrophages and neutrophil recognition and response to both soluble and cell wall associated GALM,
specifically probing the role of Dectin-2 and the downstream effector Syk in cytokine production, phagocytosis,
and phagosomal maturation. Specific Aim 2 seeks to define the molecular pathways that mediate macrophage
and neutrophil responses to soluble and cell wall-associated GAG. This aim will define signaling pathways and
receptors critical for GAG mediated immunosuppression and define the role of GAG in cytokine production,
ROS generation, and phagocytosis. The candidate is a physician-scientist and has completed a clinical
fellowship in the combined Massachusetts General Hospital and Brigham and Women's Infectious Diseases
Program. She has research experience in fungal molecular biology having devoted her graduate training to
defining signaling pathways involved in virulence and the generation of diversity in the human pathogens,
Candida and Cryptococcus. Her overall career goal is to be an independent investigator capable of probing the
host-pathogen interface. Therefore this career development grant outlines a didactic, mentoring, and scientific
research plan that will provide the necessary training in host immunology necessary to study the dynamic
interplay between host and pathogen and become a productive independent physician-scientist.

Public health relevance
Project Narrative Invasive fungal infections are increasing in prevalence due to the growing population of immunocompromised patients and represent a significant health concern with mortality rates as high as 80%. The innate immune system is crucial for the recognition and response to fungal pathogens. This proposal seeks to identify molecular pathways critical for innate immune recognition of fungal carbohydrate antigens with the goal of developing novel therapeutic strategies.